Reward, impulsive sensation seeking and emotional dysregulation: neural mechanisms underlying risk for bipolar disorder in young adults

ABSTRACT. Bipolar Spectrum Disorders (BPSD) affect up to 4.5% of Americans, are the 4th leading cause of
disability worldwide, with onset peaking in early adulthood. Yet, it is very difficult to identify young adults at risk
for BPSD, as there are no objective biomarkers of BPSD risk. Identifying these biomarkers can be facilitated by
elucidating neural biomarkers of behaviors that predispose to key symptoms of BPSD: hypomania and mania.
While emotional dysregulation characterizes BPSD, it also characterizes, and predisposes to, anxiety,
depression, and anxiety, affective and personality disorders. Impulsive sensation seeking (ISS) comprises the
component traits impulsivity and sensation seeking. High trait ISS characterizes BPSD, and predisposes to
hypomania and mania in young adults. Thus, high trait ISS predisposes to hypo/mania, and emotional
dysregulation, to anxiety and depression. The combination of both may ultimately confer risk for BPSD. In the
first 4 years of R01MH100041, examining neural biomarkers of dimensions of psychopathology and 1-year
outcome neural predictors in transdiagnostically-recruited young adults, we show (in n=100) a positive
association between trait ISS and activity in reward circuitry: left ventrolateral prefrontal cortex (vlPFC) and
ventral striatum (VS) during uncertain reward expectancy (RE). Greater left vlPFC and VS activity to uncertain
RE is also shown by BPSD vs healthy adults. In MH100041, greater left vlPFC-parietal cortical functional
connectivity (FC) to uncertain RE is associated with greater mania severity 6 months post scan; and greater
left VS-left vlPFC resting state FC, with higher trait ISS. By contrast, greater amygdala activity, and lower
amygdala-dorsal/rostral anterior cingulate cortical (dACC/rACC) FC, during emotion processing and regulation
are associated with greater emotional dysregulation, anxiety and depression, and risk for anxiety, affective and
personality disorders. Elevated reward circuitry activity and FC to uncertain RE and rest are thus promising
neural biomarkers of hypo/mania risk, and, with the above amygdala-ACC abnormalities, may predispose to
BPSD. We propose a renewal of MH100041 to: 1. Replicate and extend our neural biomarker findings in a new
cohort of 180 young adults (18-30 years; recruited transdiagnostically; no BPSD); 2. Determine if these neural
biomarkers are present in a new group of 60 age- and gender-ratio-matched adults with BPSD (30 bipolar
disorder I, 30 bipolar disorder II, prototypical types of BPSD; remitted to avoid confounds of high severity
symptoms; unmedicated/ specific medications); 3. Identify across original and new non-BPSD cohorts neural
biomarkers of trait ISS and emotional dysregulation that predict worsening hypo/mania vs. worsening anxiety
and depression over extended (2 years’) follow up, and explore which neural biomarkers predispose to BPSD
vs. other disorders. Identifying neural biomarkers of BPSD risk will help to better identify BPSD at-risk young
adults, and provide neural targets for novel (e.g., neuromodulation) interventions to delay, or prevent, BPSD.

Public health relevance
PROJECT NARRATIVE. Bipolar Spectrum Disorders (BPSD) affect up to 4.5% of Americans, and are the 4th leading cause of disability worldwide; yet, it is extremely difficult to identify young adults who are at risk for BPSD, as there are no objective markers of risk for these disorders. We propose a renewal of a study of young adults (R01MH100041), in which we have identified brain imaging markers of specific behaviors that predispose to key symptoms of BPSD, hypomania and mania, vs. symptoms common to a range of psychiatric disorders, where we aim to: 1. replicate and further examine findings in an independent cohort of 180 young adults who have not yet developed BPSD; 2. determine if the above brain imaging markers are common to 60 young adults with BPSD; 3. determine which of these brain imaging markers, in aggregate with and over and above clinical and demographic measures, predict future hypomania and mania, or worsening of these symptoms, vs. onset and/or worsening of other symptoms that are common to a range of different psychiatric disorders; and explore whether these markers predispose to BPSD vs. other disorders. Identifying brain imaging markers of BPSD risk will help to better identify BPSD at-risk young adults, and provide specific brain targets for new (e.g., brain stimulation) interventions to delay, or even prevent, onset of BPSD in vulnerable young adults.